Physical Resilience Prediction in Advanced Renal Disease

ABSTRACT
Background: Older Veterans with advanced chronic kidney disease (CKD) face complex decisions to initiate
or forgo dialysis in the context of uncertainty about their future health and physical function. Making these
decisions is complicated by the course of advanced CKD which is characterized by frequent health events that
further worsen function. Decisions support tools are needed that are specific to the clinical course of advanced
CKD and predict outcomes that matter most to these patients, such as physical function. Characterizing how
patients ‘bounce back’ from health events, such as illnesses or injuries that result in emergency department
(ED) visits or hospitalizations may be key to predicting future functional status. This approach draws from the
novel geriatric concept of physical resilience, defined as one’s ability to resist or recover from functional decline
following a ‘health stressor.’ Objectives: To help older Veterans make informed decisions about kidney
disease treatment by better characterizing physical resilience and identifying patient factors associated with
physical resilience to develop a prediction tool for physical resilience in advanced CKD. This addresses the
HSR&D priority of Patient-Centered Care domain. To do this, we propose Physical REsilience Prediction in
Advanced REnal Disease (PREPARED), a prospective cohort study of older Veterans with advanced CKD with
the following Aims:
1. To characterize physical function trajectories before and after an acute health stressor in order to define
physical resilience among older Veterans with advanced CKD.
2. To identify associations between patient characteristics and physical resilience trajectory and potential
candidate variables for prediction model development.
3. To develop a prediction tool for physical resilience (where this quantity has been defined in Aim 1).
4. To determine the association of physical resilience with short-term mortality.
Methods: We will conduct a longitudinal cohort study of 800 Veterans ≥ 70 years old, with an estimated
glomerular filtration rate (eGFR) < 30 ml/min/1.73 m2 (excluding dialysis or transplant), and 90-day probability
of hospitalization ≥ 50% (based on the Care Assessment Needs [CAN] score). Telephone assessments will
include brief validated measures of function every 8 weeks, and within 14 days following a stressor for up to 6
calls. In Aim 1, we will characterize physical resilience, first by identifying latent classes of physical resilience
trajectories using general growth mixture modeling. Next, among the subset from the physical resilience latent
trajectory class we will fit a piecewise linear mixed effects model to quantify resilience. In Aim 2, we will
determine how the physical function trajectory is moderated by person-level health and psychosocial factors
and organ system-level physiologic factors. This information will be used to identify potential candidate
variables for our prediction model in Aim 3. The purpose of Aim 4 is to determine the prognostic importance of
physical resilience by examining the relationship between experiencing a stressor and physical resilience with
6-month mortality. Impact: The proposed study addresses the most pressing clinical dilemma in this complex
condition that disproportionately affects older Veterans. Data on physical resilience from the proposed study
will be used to develop a practical tool to address a vital question that CKD patients, their families, and
providers face when making treatment decisions. Limiting uncertainty about future health by predicting
resilience will support individualized and patient-centered decision-making for kidney disease. Next steps: We
will develop a clinical trial to test the use of our physical resilience prediction tool and work with our local and
national operations partners (Durham VA Renal Service, Office of Geriatrics and Extended Care, Renal Field
Advisory Committee) to implement physical resilience assessment into care for these patients.

Public health relevance
Older adults with advanced chronic kidney disease (CKD) often make difficult decisions about their medical treatment without knowing what might happen to them. Because CKD patients worry about losing the ability to care for themselves or requiring help from others to carry out their daily activities, it would be helpful to know what might happen if they had a sudden health problem, such as an illness or injury. Physical resilience is a new concept that describes one’s ability to recover after a health problem. People who are physically resilient bounce back to the physical level before the health problem. In the current study we will use medical records and telephone surveys to observe physical resilience in older Veterans with advanced CKD. We will determine what traits or characteristics help Veterans have physical resilience, develop a tool to help patients and their doctors better identify those who are resilient, and determine the association between physical resilience and mortality. This information will be used to help Veterans make decisions about kidney disease treatment.